Utilizing multimodal neuroimaging to identify neurometabolic and neurobehavioral correlates of adolescent binge drinking

PROJECT SUMMARY/ABSTRACT
Adolescent binge drinking (5+ drinks for males, 4+ drinks for females) is problematic and associated with many
negative psychosocial consequences, such as progression into early and persistent alcohol use disorder (AUD).
Research on neuroscience-informed treatments for adolescent AUD is sparse, but needed, and must be tailored
to the adolescent population rather than extrapolating from the adult AUD literature. This requires a
comprehensive knowledge of the neurobiological effects of problematic alcohol use in youth, making binge
drinking adolescents a critical sample in the adolescent AUD pharmacotherapy development pipeline.
Neurobiological research within binge drinking adolescents, as compared to their non-drinking peers, will help to
identify mechanisms of alcohol action in the developing brain, which will ultimately translate to targets for
pharmacotherapy development for adolescent AUD. Additionally, sex-specific neural effects of binge drinking
need to be better understood to ensure efficacious treatments for both males and females. The proposed study
employs multimodal neuroimaging (magnetic resonance spectroscopy [MRS] and functional neuroimaging
[fMRI]) to investigate the neurometabolic (measured with MRS) and neurobehavioral (measured with fMRI)
effects of binge drinking in youth, as compared to non-drinking controls. This project will help to address the
current literature gap concerning neurometabolic alterations in glutamate, GABA, and glutathione (all metabolites
dysregulated by alcohol use) associated with adolescent binge drinking, and how such changes relate to alcohol
cue reactivity and sex as a biological variable (SABV). Aim 1 quantifies glutamate, GABA, and glutathione in the
anterior cingulate cortex (ACC) in binge drinkers, as compared to non-drinking controls, using MRS. Aim 2
explores the association between brain metabolite levels (glutamate, GABA, and glutathione) and alcohol cue
reactivity measured with fMRI in binge drinking youth, as compared to controls. Aim 3 examines SABV within
these neural correlates of adolescent binge drinking, as compared to non-drinking controls. Findings will identify
neural targets for the development of pharmacotherapy treatments for adolescent AUD. This F32 application is
built upon baseline neuroimaging data from a nearly complete clinical pharmacotherapy trial (PI Squeglia) with
an added non-using control group (PI Kirkland; internal pilot project funding), making it highly feasible within the
proposed timeline. The research proposed in this F32 application will serve as essential hands-on training to
promote the candidate’s career development in adolescent alcohol use disorder neurobiology and neuroimaging
research, and it will result in a dataset on which to build an NIH K-award grant application using an advanced
multimodal imaging platform to evaluate promising pharmacotherapies for adolescent AUD.

Public health relevance
PROJECT NARRATIVE The proposed project employs multimodal neuroimaging (magnetic resonance spectroscopy [MRS] and functional magnetic resonance imaging [fMRI]) to better understand the neural effects of adolescent binge drinking with the ultimate goal of identifying high-yield treatment targets for adolescent alcohol use disorder (AUD). Importantly, this project will also examine the effects of sex as a biological variable (SABV) on the neural correlates of binge drinking to promote equitable efficacy of future candidate medications. Finding neuroscience- informed treatment targets is critical as early intervention in a youth’s drinking trajectory could reduce the likelihood of transitioning from binge drinking during adolescence to AUD during early adulthood, thereby reducing costs to the person, healthcare system, and society.